Biogeography of Aquatic Pathogens in Hawaiian Watersheds

Project Summary – PROJECT 1: JI, Kiana Frank
Despite large advances in water and wastewater treatment, waterborne diseases still pose a major worldwide
threat to public health. However, most waterborne pathogens are unmonitored, and their adverse effect on
human health and productivity can only be controlled by obtaining a thorough understanding of their incidence,
environmental niches, and the epidemiology of the diseases they cause. The goal of this proposal is to
evaluate how land-use patterns and environmental factors influence the diversity, abundance, virulence and
persistence of waterborne microbial threats in Hawaiian watersheds - as a model to improve our understanding
of the global pathogen diversity and of the environmental forces shaping it. The overarching hypothesis is that
factors associated with urbanization contribute to increased pathogen abundance, diversity and distribution. By
integrating field sampling, experimental approaches, geochemistry and genomics this proposal will (i)
characterize the biogeography of aquatic pathogens in three Hawaiian watersheds; (ii) define the bases of the
observed patterns of pathogen diversity and density; and (iii) test the influence of physical and chemical
variables on pathogen dynamics. This work will enable biogeographic modeling of these dynamics to predict
threats across geochemical and anthropogenic gradients, aid in the development of more efficient, accurate
and reliable molecular screening tools, and foster a more informed public on the presence and risks of
pathogens in their environment. It is also highly relevant to broad goals currently driving epidemiology and
environmental microbiology. This project will take full advantage of the proposed Microbial Genomics and
Analytical (M-GAL) Core, as well as the Microscopy Imaging Center for Research through Observation
(MICRO) and the University of Hawaii's Cyberinfrastructure Core. The impact of this research is synergistic
with that of COBRE Projects 2-5, serving as a foundation to understand microbial interactions with the physico-
chemical environment - from free-living to symbiotic organisms - and their influence on human health.